Cancer Research Training and Education Coordination

PROJECT SUMMARY/ABSTRACT (CANCER RESEARCH TRAINING AND EDUCATION COORDINATION)
The Rogel Cancer Center (Rogel) is dedicated to training and developing the next generation of
cancer researchers and providers. Rogel established the Training, Education and Career Development
(TrEC) Office to lead coordination and development of programming for all levels of trainees and across the
continuum from basic to population research. Rogel has committed a 5-fold increase of funds during the
current period to over $1M in annual support. Rogel boasts an exemplary track record of established NCI-
funded research training programs for over 30 years. Graduates from Rogel-affiliated training programs
– from basic research to population sciences – serve as leaders in major academic centers across the
country. Through its TrEC initiatives, Rogel has had a sustained and prominent impact on cancer research
and the training of the oncology workforce nationally and internationally. Rogel trainees have achieved
success across all levels and relevant metrics, further solidifying the major and sustained impact that
Rogel has had on developing future cancer researchers and leaders. Rogel TrEC coordinates and provides
cancer focused training and career development opportunities for all levels of trainees, and as result, serves a
key bridging role in engaging trainees in cancer related career development and linking trainees to each other
and to members outside their home units. Rogel fosters a training environment that robustly supports
transdisciplinary, translational and team science in cancer research as well as Rogel cross-cutting research
themes and catchment area priorities, while ensuring the individual career development of future cancer
research leaders. Faculty members and trainees participate in educational outreach initiatives in partnership
with Rogel Community Outreach and Engagement (COE) and with Rogel Diversity, Equity, Inclusion and
Justice (DEIJ) initiatives to further inform their learning about the CA, high priority cancers and support for DEIJ
across all aspects of the cancer center.